OUTPATIENT TREATMENT OF BRONCHIOLITIS-- ALBUTEROL BY METERED DOSE INHALATION

To find out if albuterol works in treating bronchiolitis, children will be given two treatments of mist with medicine and two treatments of mist without medicine. This is a double-blind study. A sample of mucus is extracted from each child's nose and sent for analysis.